Revealing Cellular Determinants of LINE-1 Retrotransposition Outcomes

Project Summary
Transposable elements (TE) are endogenous mutagens, that contribute to germline and somatic genetic
mosaicism and disease formation. Long interspersed element 1 (LINE-1, L1), one TE family that occupies
nearly one-fifth of the human genome, is an active, protein-coding retrotransposon that can ‘copy-and-paste’
itself to generate de novo genomic insertions using an RNA intermediate, a process called retrotransposition.
Although most genomic copies of L1 (~500,000 copies) are immobile, there are ~100 loci in human cells that
are retrotransposition competent. L1 activity is normally suppressed by epigenetic and DNA repair pathways.
Conversely, loss of these suppressive mechanisms can lead to L1-mediated insertional mutagenesis,
disrupting functions of disease-causing genes. Recent studies suggest that L1 retrotransposition may be a
source of DNA damage, promoting chromosome breaks and translocations. Key studies have shown that L1
retrotransposition can lead to complex insertion outcomes (e.g., full-length L1 (~6kb, retrotransposition
competent), truncated L1 (varying in length, retrotransposition incompetent), and chromosomal translocations,
etc.), yet the frequency of these outcomes and their underlying mechanisms remain poorly understood. To
date, only a few hundred de novo L1 insertions have been published, limiting our understanding of these
mechanistically complex events. 1) Traditional retrotransposition reporters can only detect insertions >2kb,
missing the more common shorter insertions (<0.5kb); 2) Sequencing L1 insertions is difficult due to their
variable length (up to 6kb) and sequence similarity; 3) Short-read sequencing often does not inform the entire
length of an insertion or allow for the assembly of an L1 inserted at a chromosomal breakpoint. To address
these challenges, I am developing innovative long-read sequencing approaches to capture entire L1 insertions.
These breakthroughs provide unprecedented opportunity to study factors that determine insertion outcomes
and enable me to address these specific aims. Aim 1 (K99) - Delineate the impact of ORF2p in determining L1
insertion outcomes. Aim 2 (K99/R00) - Investigate the roles of DNA replication and DNA repair in shaping L1
insertion outcomes. Aim 3 (R00) - Map L1 insertions in patient samples with genetic disease. These studies
will be the first to leverage state-of-the-art long-read sequencing technologies to identify critical factors that
affect L1 insertion outcomes. Research in my R00 phase will provide insight into the contribution of L1
mediated genetic mosaicism in genetic diseases.

Public health relevance
Narrative L1 retrotransposition is a complex process orchestrated by L1-encoded proteins, their interacting partners, and cellular host factors, including DNA repair mechanisms, which together produce diverse genomic insertion outcomes. Dissecting key determinants of L1 mutagenesis is crucial to understand retroelement propagation and roles for L1 in human health and disease. The proposed studies will be the first to leverage state-of-the-art long-read sequencing technologies to identify critical retroelement and host factors that affect L1 insertion outcomes and will probe the contribution of L1-mediated somatic mosaicism in genetic diseases.